WASp signaling in T-cell lymphomas

ABSTRACT
Title: WASp signaling in T-cell lymphomas
Peripheral T-cell lymphomas (PTCL) are aggressive disorders, with less than 50% overall survival after 2-3
years of diagnosis. These dismal outcomes are in no small part secondary to the limited number of available
biomarkers of disease progression and the limited knowledge of T-cell lymphoma biology. Emergent evidence
indicates that the actin cytoskeleton plays a pivotal role during T-cell lymphomas' development and growth;
however, actin-related proteins' role as actionable targets in T-cell lymphomas still needs to be defined. Our
preliminary findings demonstrate that the actin regulatory protein Wiskott-Aldrich syndrome protein (WASp) is
associated with decreased event-free survival and promotes T-cell lymphoma growth and survival. In this
proposal, we will leverage a genetically engineered murine (GEM) model that develops spontaneous peripheral
T-cell lymphomas (SNF5FL/CD4cre), and we will capitalize on an international consortium of more than 100 T-cell
lymphoma cases collected with accompanying annotated clinical outcomes, to test the role of WASp during the
assembly of actin-dependent signaling complexes upstream of oncogenic transcriptional signaling, and define
the role of the tumor microenvironment driving WASp-dependent oncogenic signaling.

Public health relevance
NARRATIVE The proposed research is relevant to public health because peripheral T-cell lymphomas are diagnosed in approximately 10,000 individuals in the U.S. annually. More than 70% will relapse after initial chemotherapy, and no current standardized therapies are at the relapse stage. This proposal aims to determine the relevance of novel actionable targets in T-cell lymphomas and is relevant to the NIH’s goal to foster fundamental creative discoveries, innovative research strategies, and their applications as a basis for ultimately protecting and improving health.